MISOPROSTOL INHIBITION OF SYSTEMIC MAST CELL ACTIVATION

This study is to assess the efficacy of treatment with misoprostil to inhibit episodes of systemic mastocyte activation in patients with idiopathic anaphylactoid attacks, aspirin-induced anaphylactoid attacks, and systemic mastocytosis. This has been a long-term study on which we track the patients. New treatment regimens are being will be developed for these patients.